Supporting Just-in-Time Consent for Prenatal Screening

PROJECT SUMMARY/ABSTRACT
Prenatal screening for genetic conditions (PGS) has changed the landscape of prenatal care by offering
noninvasive indication of some fetal genetic conditions. PGS should be clearly distinguished from prenatal
diagnostic testing using microarray analysis of amniotic fluid, which is considered the gold standard for fetal
genetic assessment. While other routine screens are not held to the standard of fully informed consent, the ethics
literature on PGS, from maternal serum screening to cell-free DNA and other technologies, has argued that PGS
requires higher levels of consent based on the exceptional nature of its informational impacts, including potential
abortion decisions based on fetal characteristics. Multiple studies examining the patient experience have
described or proactively expressed concern at the routinization of PGS, including insufficient pre-test counseling
and ethical reflection on whether PGS was the right approach for the patient and family, consistent with their
values on disability and abortion. However, our own research on the implementation of PGS in low-resource
settings in the U.S. has found that there are few resources to attempt, let alone achieve, fully informed consent
prior to screening. Furthermore, for the great majority of pregnancies that do not receive a high-probability PGS
screen, attempting fully informed consent introduces mental and psychological stress on pregnant individuals
that may be unnecessary and undesirable. Patients who receive screen-positive results do require extensive
information and support for pregnancy and parenting decision-making, but they represent a tiny minority of all
those screened. Thus, we argue that a model of just-in-time consent (JITC) for PGS, incorporating simple
consent with shared decision-making, better fulfills the goals of prenatal screening and locates intense moral
decision-making in a more appropriate place in the pregnancy journey. JITC acknowledges the increased moral
weight that prenatal screening may have over other routine screens without burdening pregnant individuals and
health systems with unnecessary consent procedures. We propose a clinical trial over three demographically
and geographically diverse sites that serve a large pregnant population from historically underserved
communities to compare a novel JITC mechanism to current care. Our Aims are: (1a) Conduct community
engaged research with patients and providers to understand the necessary components of JITC for PGS; (1b)
Design and pilot a mobile-based intervention to deliver knowledge elements necessary for JITC for cfDNA; (2)
Using a stepped-wedge design, implement the mobile-based intervention at three diverse sites and evaluate
outcomes of feasibility and decisional satisfaction; and (3) Develop data-based, ethically informed
recommendations regarding implementation of a just-in-time consent model for patients receiving high risk PGS
screening test results.

Public health relevance
PROJECT NARRATIVE This study will compare a novel, mobile-friendly, just-in-time consent model to current ways of offering prenatal genetic screening. The clinical trial will recruit at three diverse sites that serve a large pregnant population from historically underserved communities. The goal is to build an ethical and realistic approach to helping pregnant patients make informed decisions about prenatal genetic screening.